B cell receptor dependent infection as a mechanism of immune-mediated enhancement of dengue virus infection and pathogenesis

Four serotypes of dengue virus (DENV1-4) cause 100 million symptomatic dengue cases annually. While the
majority of DENV infections resolve without the need for medical intervention, dengue can quickly progress in
some patients to potentially fatal dengue hemorrhagic fever (DHF) or dengue shock syndrome (DSS). The risk
factors associated with progressing to severe dengue are complex and incompletely understood. However, the
risk of developing severe disease increases significantly in individuals experiencing secondary/heterologous
infections. The leading mechanistic explanation for this phenomenon is Antibody-Dependent Enhancement
(ADE), wherein DENV-specific IgG antibodies elicited by a prior heterotypic DENV infection opsonize DENV
without neutralizing infectivity, facilitating uptake by FcγR-bearing phagocytes such as monocytes and
macrophages. However, analysis of samples from individuals experiencing acute DENV infection reveals that B
cells are the largest reservoir of infected circulating cells, representing a disconnect in our understanding of
immune-mediated DENV tropism. While B cells are known to be phagocytic, their antigen-specific receptors
provide an additional means of internalizing extracellular antigens. Our team has recently demonstrated that the
expression of a DENV-specific B cell receptor (BCR) renders cells highly susceptible to DENV infection. In
addition, we have demonstrated that the frequency of DENV-infectable B cell is influenced by flavivirus immune
status, with the frequency of DENV-infectible B cells increasing significant in previously flavivirus-naïve
individuals after a primary DENV infection. We posit a new paradigm where cross-reactive non-neutralizing
antibodies, when expressed in their transmembrane form as B cell receptors (BCR) on DENV-specific B cells
are capable of mediating BCR-dependent enhancement (BDE) DENV infection, replication, and
immunopathogenesis. Our long-term goal is to understand how B cells themselves alongside their antibody
products can contribute to protection from or susceptibility to DENV infection and disease. Accordingly, our
objective with this submission is to define the mechanistic requirements underpinning the process of BDE and
to understand how risk of BDE is modulated by DENV infection and/or vaccination.

Public health relevance
Dengue virus (DENV) is a widespread mosquito-borne pathogen that infects an estimated 400 million people every year. The severity of DENV infection can range from asymptomatic to life-threating. Despite the significant and growing healthcare burden posed by infection with DENV we still don’t understand why some people fall severely ill after infection while some experience few – if any- symptoms. The goal of this research project is to understand how DENV can coopt the immune system to increase infection and pathogenesis, specifically infecting immune cells that – under different circumstances – might provide protection from infection.